Effects of early vs. late time restricted eating vs. daily caloric restriction on weight loss and metabolic outcomes in adults with obesity

The goal of this proposal is to determine the optimal time restricted eating (TRE) window to produce weight loss in adults with overweight or obesity. Daily caloric restriction (DCR), the current standard of care dietary strategy for weight loss, produces 5-7% weight loss in the context of a guidelines-based behavioral weight loss program, yet adherence is challenging and weight regain is common. Thus, rigorous evaluation of the effectiveness of novel dietary interventions is needed to provide a range of evidence-based options to effectively treat obesity. TRE involves restriction of energy intake (EI) to a limited window of time each day and has been widely promoted in the lay press, but TRE studies to date have shown only minimal (0-4%) weight loss. However, prior TRE studies have several substantial limitations, including small sample sizes, short duration, and failure to provide appropriate obesity treatment guidelines-based behavioral support. While several different dietary strategies can be used to achieve energy restriction, behavioral support is critical to enhancing adherence to both diet and physical activity (PA) recommendations and thus weight loss outcomes, yet no prior studies have provided behavioral support for TRE. Further, most TRE studies to date have utilized late TRE windows (L-TRE, e.g., eating window 12-8 PM), often providing the rationale that participants are more likely to adhere to L-TRE rather than early TRE (E-TRE, e.g. eating window 8AM-4PM). However, there is strong rationale from mechanistic studies to suggest E-TRE may result in greater weight loss and cardiometabolic benefits than L-TRE. We have shown that E-TRE results in improvements in glucose variability and insulin sensitivity, clinically significant weight loss (6.3 ± 4.1% at 12 weeks), as well as improvements in dietary quality, increased PA, reduced sedentary time and subjective improvements in sleep. However, we did not include a L-TRE control, so it is unclear whether the E-TRE window or the provision of behavioral support enhanced weight loss outcomes as compared to prior TRE studies. Thus, a rigorously designed trial is needed to evaluate the impact of E-TRE and L-TRE delivered in the context of a guidelines-based behavioral intervention on weight loss and cardiometabolic outcomes. In this study, 108 adults with overweight or obesity will be randomized 1:1 to E-TRE (8-hr window starting at 8 or 9AM, depending on habitual wake time) or L-TRE (8-hr window starting at noon or 1pm, depending on wake time) for 26 weeks (primary outcome), with follow up at 52 weeks. Our aims are to compare the effects of E-TRE and L-TRE on: 1) Changes in body weight and composition and markers of cardiometabolic health; 2) Dietary adherence, EI and dietary quality; and 3) PA and sleep. Our overall hypothesis is that E-TRE will result in greater weight loss and improvements in cardiometabolic outcomes as compared to L-TRE. In addition, we hypothesize that adherence to E-TRE and L-TRE will be similar, but E-TRE will result in greater reductions in EI, adherence to PA and improved sleep duration/quality as compared to L-TRE.

Public health relevance
PROJECT NARRATIVE There is a critical need for effective nutritional strategies to limit energy intake and regulate appetite, and one such strategy that has gained increasing attention is time restricted eating (TRE), or restriction of food intake to a specific window of time during the day. The goal of this project is to evaluate the effects of a 52-week behavioral weight loss program using early vs. late timing of TRE as compared to standard of care (daily caloric restriction) on body weight and cardiometabolic outcomes. This project may result in changes in dietary recommendations and is therefore of significant benefit to public health.